Multipopulation voltage imaging for network insights in temporal lobe epilepsy

PROJECT ABSTRACT
The hippocampus is a critical structure in mesial temporal lobe epilepsy (TLE), and is comprised of different
cell types and subcircuits. How these circuit elements behave and importantly how they interact may provide
key insights into epilepsy, including ictogenesis. Epilepsy is recognized as a “network disorder”; a proper
understanding of network interactions in epilepsy is crucial to a full understanding of the disorder and
consequently the development of novel treatment options. A new suite of voltage indicators allows unparalleled
and simultaneous investigation of such circuit elements. We will therefore apply these cutting-edge methods in
vivo, in awake, chronically epileptic animals, allowing us to answer questions not currently addressable with
other methods – examining features including subthreshold membrane potential changes and resolving
individual spikes even during high levels of activity. Using a mouse model of chronic TLE, we will image during
periods free of overt epileptiform activity, during interictal spikes, during preictal periods, and throughout ictal
activity, as well as postictal periods – providing us will a full picture of activity patterns across different ictal
states. In this initial work, we focus on CA1 pyramidal neurons that project to the medial prefrontal cortex
(PCmPFC) and CA1 pyramidal neurons that project to the medial entorhinal cortex (PCMEC), in addition to
inhibitory neurons, including PV neurons specifically. These circuit elements were chosen due to their known
and distinct interactions. Specifically, PCmPFC provide strong excitation to local PV neurons, but receive little
inhibition from PV neurons. Conversely, PCMEC receive strong inhibition from local PV neurons but provide
relatively limited excitation to PV neurons. We will therefore be able to examine, for the first time, how these
circuit elements’ activity patterns relate to one another in vivo and how this changes in epileptic animals across
the ictal spectrum. We predict that PV interneurons’ activity will be associated with reduced PCMEC but not
PCmPFC pyramidal neuron activity in epileptiform-free states. During interictal spiking, we hypothesize that
interneurons broadly are activated and that inhibition will constrain activity in both populations of pyramidal
neurons during these events. We further predict that, unlike during interictal spikes, during ictal events,
inhibitory neuronal firing will not be sufficient to restrain pyramidal cells, and they will be engaged even early
during electrographic seizures. With continued ictal activity, we hypothesize that there will be a further
breakdown in inhibitory restraint due to depolarization block in PV cells (but not other interneurons), resulting in
a further increase in activity specifically in PCMEC neurons. If our hypotheses are incorrect, we gain equally
valuable information about the activity patterns of these neuronal populations in chronic epilepsy. Additionally,
this represents a fraction of the hypotheses testable with our data set and with future application of these
methods to questions in epilepsy. We are committed to ensuring that the epilepsy community can implement
these methods to address a wide range of important questions.

Public health relevance
PROJECT NARRATIVE The hippocampus, a brain region critical in temporal lobe epilepsy, is composed of circuit elements, which impact each other in distinct ways. Studying these elements and their interactions is important for understanding epilepsy and ultimately developing novel treatment approaches. This proposal uses state-of- the-art voltage imaging methods to simultaneously monitor defined populations of hippocampal neurons in a mouse model of temporal lobe epilepsy, to gain critical insights into the activity patterns of these circuit elements interictally and ictally.